RECK in Pulmonary Fibrosis

PROJECT SUMMARY/ABSTRACT: Idiopathic pulmonary fibrosis (IPF) is a progressive, fatal lung disease,
and there is a large unmet need for effective therapies. IPF is characterized by epithelial injury and subsequent
aberrant activation of fibroblasts which lay down excessive extracellular matrix (ECM) proteins (e.g., collagen).
ECM turnover/remodeling and activation of TGF-β1 (the master regulator of fibrosis, which is incorporated in
ECM in a latent form) are regulated by a delicate balance between matrix metalloproteinases (MMPs) and their
inhibitors, through interactions among cells such as epithelial cells, fibroblasts, and macrophages.
Our recent data suggest that 1) reversion-inducing cysteine-rich protein with Kazal motifs (RECK), an
MMP inhibitor, is significantly downregulated in human IPF lung samples, and this downregulation is correlated
with reduced lung function; 2) RECK expression is downregulated in the lungs of mice treated with bleomycin,
particularly in monocytes (but also in other types of cells such as epithelial cells and stromal cells); and 3) mice
overexpressing RECK under the lysozyme 2 (Lyz2) promoter, which is widely used to target myeloid cells
(including monocytes), recover from bleomycin-induced pulmonary fibrosis more quickly than their RECK wild-
type controls. The mechanisms underlying how RECK influences progression and resolution of pulmonary
fibrosis remain unknown.
Based on our data, we hypothesize that RECK expressed in monocytes and other types of cells
mediates resolution of fibrosis in a bleomycin-induced pulmonary fibrosis mouse model. We will test this
hypothesis with two specific aims. In the first aim, we will determine the effects of myeloid-specific RECK
overexpression on 1) temporal regulation of fibrosis, by measuring the amount of collagen accumulated in the
lungs and assessing lung function over time; and 2) cytokine secretion, TGF-β1 activation, and fibroblast
activation by monocytes/macrophages isolated from RECK wild-type mice and myeloid-specific RECK
overexpression mice. In the second aim, we will determine the effects of global (cell-type non-specific) RECK
overexpression on temporal regulation of fibrosis. We will compare the magnitude of fibrosis resolution
between the myeloid-specific RECK overexpression mice and the global RECK overexpression mice, to
determine the cell compartments that mediate fibrosis resolution via RECK. We will also determine the effects
of RECK overexpression on lung transcriptome and the interactions between different types of cells, using
single-cell RNA sequencing.
We anticipate that we will reveal mechanisms whereby RECK expressed in monocytes and other types
of cells promotes resolution of fibrosis and demonstrate the therapeutic potential of RECK overexpression for
pulmonary fibrosis.

Public health relevance
Idiopathic pulmonary fibrosis (IPF) is a progressive and fatal lung disease, despite the advent of two new medications (pirfenidone and nintedanib); therefore, more effective therapies are needed. However, the underlying biological mechanisms that regulate fibrosis are still poorly understood. This proposal aims to understand how a protein called REversion-inducing Cysteine-rich protein with Kazal motifs (RECK) regulates pulmonary fibrosis, using genetically engineered mouse models and state-of-the-art techniques including gene sequencing.